Role of PrRP+ projections to BNST in ethanol withdrawal and negative affective behavior

Project Summary/Abstract
Negative affect and stress experienced during alcohol abstinence can be a major factor contributing to relapse
in alcohol use disorder, yet underlying neurobiological mechanisms remain ill-defined. Corticotropin-releasing
factor (CRF)-expressing neurons in the bed nuclei of the stria terminalis (BNST) are involved in anxiety and
stress responses, and they play a major role in the withdrawal. A subcommissural population of CRF neurons
in the BNST (vBNSTCRF) is heavily innervated by hindbrain noradrenergic neurons that co-express prolactin
releasing peptide (PrRP). Because these PrRP neurons are sensitive to both stress and interoceptive state,
they are likely involved in the development of stress hypersensitivity following withdrawal. However, the role of
PrRP neurons in alcohol-related behaviors has not been studied. I hypothesize that signaling of PrRP neurons
to vBNST during acute ethanol withdrawal contributes to the development of negative affective behaviors, and
that ethanol withdrawal potentiates vBNSTCRF responses to stress and PrRP neuronal activation. In the
proposed project, mice will undergo chemogenetic silencing of PrRP+ neurons projecting to vBNST during
acute ethanol withdrawal to examine the necessity of the circuit in the development of negative affective
behaviors (Aim 1). Then, the influence of ethanol withdrawal on in vivo calcium responses of vBNSTCRF
neurons to stress and chemogenetic activation of PrRP+ neurons will be explored using fiber photometry (Aim
2). Finally, monosynaptic tracing and whole brain imaging will be used to define additional brain regions
innervating vBNSTCRF neurons that may be modulated concomitantly during ethanol withdrawal (Aim 3). The
results of these studies will provide an improved understanding of neurobiological mechanisms impacting
affective behavioral changes during ethanol abstinence. This project also provides a strong platform to expand
and strengthen the trainee’s expertise in modern behavioral neuroscience approaches, including intersectional
viral strategies for chemogenetic manipulation of neural circuits, observation of cell-type specific in vivo
calcium signaling, and characterization of monosynaptic inputs to specific cell populations.

Public health relevance
Project Narrative Negative affect and stress experienced during alcohol abstinence can be a key contributor to relapse in individuals with alcohol use disorder. This proposed research will provide important insight into the neural circuitry underlying the development of negative affective behaviors and stress hypersensitivity during ethanol abstinence. The findings from this research have the potential to identify novel therapeutic targets and inform the development of more effective treatments for individuals with alcohol use disorder.